Thalamo-prefrontal circuit maturation during adolescence

Adolescence is a window of vulnerability for the development of schizophrenia and other mental disorders. In
schizophrenia, imaging studies have found that thalamo-prefrontal resting state connectivity is reduced during
adolescence prior to disease onset. This decrease in functional connectivity has been linked to cognitive
symptoms and the etiology of the disorder. For many years, an altered maturation of the prefrontal cortex (PFC)
has been implicated in the cognitive deficits of mental disorders yet the mechanisms that drive PFC maturation
are largely unknown. Because thalamic input activity is important for circuit maturation in sensory cortices, we
hypothesize here that thalamic input activity is also important for prefrontal circuit maturation.
To address whether adolescence is a sensitive time-period during which thalamic activity regulates the
maturation of PFC circuitry, we used mice and compared the effects of reducing activity in the thalamic nuclei
projecting to the PFC during postnatal days P20-50 with that in adulthood (P90-120). We found that inhibiting
the thalamus during adolescence leads to a long-lasting decrease in the density of thalamo-mPFC projections
and a reduced excitatory drive to mPFC neurons. Adolescent thalamic inhibition further causes cognitive deficits
in attentional set shifting during adulthood that are associated with disrupted correlated neuronal activity and
task outcome encoding in the mPFC. In contrast, thalamic inhibition during adulthood has no long-lasting
consequences on mPFC excitation, correlated activity, outcome encoding and behavior. Strikingly, exciting the
thalamus in adulthood during the set shifting task rescues in vivo neuronal activity and cognitive deficits induced
by adolescent inhibition.
While these data point to adolescence as a sensitive time window for PFC circuit maturation the underlying
mechanisms by which adolescent inhibition impairs mPFC maturation are still unclear. To address this, first, the
development of mPFC circuitry needs to be characterized during adolescence. Second, it will be important to
determine whether adolescent inhibition induces long-lasting changes in intrinsic mPFC circuitry, and which
specific mPFC projections and interneurons are regulated by adolescent thalamic inhibition. Third, it will be
important to know when such changes arise and how they relate to the changes in in vivo cross correlated activity
and outcome encoding. Our data further suggest that boosting thalamic activity could provide a strategy for
rescuing cognitive deficits in neurodevelopmental disorders. However, as presented, the beneficial effect only
occurs while the thalamus is stimulated. Therefore, strategies will need to be identified that allow for a longer
lasting rescue of the cognitive abilities. We will address these questions using three aims: Aim 1: To determine
when and where adolescent thalamic activity regulates the development of mPFC circuit connectivity. Aim 2: To
determine whether the impact of adolescent thalamic inhibition on cognition requires maturation of the mPFC.
Aim 3. To determine whether thalamic excitation can lead to a long-lasting rescue of the cognitive deficit.

Public health relevance
Project Narrative Sensitive periods during development govern circuit refinement in sensory cortices but it is unclear whether they also govern maturation of associative cortical areas such as the prefrontal cortex. Studying prefrontal circuit maturation is important for understanding psychiatric disorders with neurodevelopmental origin and altered prefrontal cortex function.